Harmonization and Joint Analysis of Human Brain Single-Cell Datasets from Neurotypical Aging Controls and Alzheimer's Disease Patients

This supplement to our R01AG076949 aims to harmonize and jointly analyze our multiome datasets from 100
neurotypical normally aging (NA) subjects from adolescence into the 90s, and 40 Alzheimer’s Disease (AD)
brains, with BRAIN Initiative-generated datasets from human brain tissue. We are implementing high resolution
mass spectrometry (HRMS) (Stephens et al., 2018; Wobma et al., 2018a; Wobma et al., 2018b), 10X Genomics
single nuclei RNA sequencing (snRNA-seq), sn Assay for Transposase-Accessible Chromatin sequencing
(snATAC-seq), Visium spatial transcriptomics (10X Genomics), and our custom-made slide-seq technology,
using deterministic barcoding in tissue for spatial omics sequencing (DBiT-seq), for co-mapping mRNAs
and proteins (Liu et al., 2020), ATAC spatial sequencing (Deng et al., 2022) and RNA-ATAC co-profiling (Zhang
et al., 2023). We will integrate our data with publicly available datasets from GEO (Gene Expression Omnibus),
SCORCH (Single Cell Opioid Responses in the Context of HIV), PsychENCODE Consortium, NeMO
(Neuroscience Multi-Omic Data Archive), SEA-AD (Seattle Alzheimer’s Disease Brain Cell Atlas), Psych-AD
(Neuropsychiatric Symptoms in Alzheimer’s Disease) and the BICCN (BRAIN Initiative Cell Census Network).
We will include external datasets on hippocampus and other brain regions, to implement analyses on gene
regulatory networks (GRNs) that are common to neurons and glial cells across brain regions, and identify GRNs
that synergistically regulate functional brain circuits involved in cognitive, emotional, and behavioral changes in
AD. The hippocampus, fundamental for memory, the amygdala, regulating emotional responses to stress and
“fight or flight” reactions, and the prefrontal cortex (PFC), involved in set shifting, attentional control, and decision
making, are all progressively affected in AD, and they are involved in AD neuropsychiatric symptoms (NPS),
such as disinhibition, impulsivity, anxiety, emotional distress, aggression, paranoid ideation, and other psychotic
symptoms. Understanding how those brain regions are regulated by cell-type specific epigenetic and gene
expression changes, will shed light on molecular mechanisms of AD pathogenesis and provide targets for new
therapeutic approaches to AD and NPS in AD. This supplement is within the scope of the active award and
improves the discovery potential of our dataset. This project will provide scalable pipelines for analyzing
multimodal and spatial omics cell profiling datasets, and will deliver a developmental and adult cell atlas of cell
type diversity. It will provide information on the regulome, the interaction between regulatory components that
control the state of expression of genes and their isoforms, their subcellular location, tissue state, development,
and pathology. These regulatory mechanisms include DNA accessibility for gene transcription, DNA methylation,
transcription factors that regulate gene transcription, RNA-protein interactions, and non-coding RNAs involved
in splicing, ribosome synthesis, degradation of mRNAs, and translation repression. The supplement will provide
broad sharing of our data via an NIH supported database and contribute to a reference atlas of human cell types.

Public health relevance
This supplement to our R01AG076949 will harmonize and jointly analyze our single nuclei and spatial multiome datasets obtained from neurotypical subjects from adolescence into the 90s and Alzheimer’s Disease brains, with BRAIN Initiative-generated datasets from human brain tissue. We will integrate multiome data from different brain regions involved in AD neuropsychiatric symptoms, including hippocampus, amygdala and prefrontal cortex, to implement analyses on gene regulatory networks that are common to neurons and glial cells across brain regions, and identify those that synergistically regulate functional brain circuits involved in cognitive, emotional, and behavioral changes in AD. This project will provide information on the regulome, the interaction between regulatory components that control the state of expression of genes and their isoforms, their subcellular location, tissue state, development, and pathology, and deliver a developmental and adult cell atlas of cell type diversity, that will be shared via an NIH supported database.